Designing a deployable and adaptable plasmonic sensing platform for infectious disease surveillance

SUMMARY
This proposal aims to address the critical need for cost-effective, sensitive, and accurate point-of-need
(PON) testing for infectious diseases by developing an adaptable and deployable sensing platform.
Currently available molecular diagnostic tests, such as polymerase chain reaction (PCR) and lateral
flow assays (LFA), exhibit limitations in terms of either ease of deployment or accuracy and sensitivity.
This tradeoff between accuracy and cost-effectiveness/distribution has hindered the containment of
the current pandemic and could limit our surveillance capabilities of emerging diseases. To overcome
these challenges, we propose to develop catalytic surface-enhanced Raman scattering (SERS)
sensors based on functional DNA sequences, offering several advantages over existing diagnostic
methods.
The long-term goal of this project is to create a sensing platform capable of detecting multiple genetic
biomarkers in liquid biopsies, enabling effective PON diagnostics. The proposed SERS sensors
provide highly multiplexed assays, improving accuracy in pathogen and variant identification.
Furthermore, these sensors offer quantifiable results that can be used for prognostic purposes,
enabling viral load determination. These SERS sensors are easily deployable and exhibit superior
sensitivity compared to LFA, resulting in more accurate PON diagnostic tests. In this project, we plan
to leverage inverse design and machine learning techniques to study the key functional DNA features
that influence sensor performance. The insights gained for optimal design rules will be used to
develop an automated sensor design algorithm capable of producing designs with predictable figures-
of-merit, given a target genetic code.
Additionally, we aim to exploit the reagentless feature of the sensors by developing lyophilized sensing
tablets containing all necessary components for the sensing process. These tablets enable on-
demand testing by simply adding the sample, thereby providing a practical means to administer this
one-pot SERS assay at the PON. To validate these advancements, a multiplexed assay will be
developed to detect SARS-CoV-2 and validated on saliva samples containing various inactivated
viruses from different SARS-CoV-2 variants. We will test the diagnostic accuracy in the identification of
viral load and specific variants.

Public health relevance
NARRATIVE The recent pandemic has revealed the critical need for cost-effective and sensitive point-of-need testing for infectious diseases. Our objective is to develop an adaptable and deployable sensing platform for multiplexed genetic biomarker detection in liquid biopsies. Our approach is to use machine learning for adaptable sensor design combined with the lyophilization and tableting or reagentless sensors for improved applicability.